Combined shortwave infrared fluorescence and Raman for real-time, high-resolution imaging through tissue

PROJECT SUMMARY
Optical imaging is a widely used technique in medicine and research, allowing tissue examination in a non-
invasive manner. A significant limitation of optical imaging methods is that tissues scatter, reflect, and absorb
light, making it difficult to obtain clear images of deeper structures. As a result, most optical imaging methods
struggle to visualize tissues more than a few millimeters beneath the surface, even when using special contrast
agents.
Our research focuses on improving deep-tissue imaging by using shortwave infrared (SWIR) technology. SWIR
imaging allows various modalities in one image, including SWIR Raman, absorption, and fluorescence imaging.
SWIR imaging has better tissue penetration due to reduced scattering and provides increased contrast than
near-infrared imaging when combined with clinically available dyes such as indocyanine green (ICG).
One of our key goals in this proposal is to develop wide-field SWIR Raman imaging (SWIRRI), which allows us
to understand the chemical composition of tissue in a label-free manner. Our preliminary studies have shown
the ability to detail subcutaneous tissue composition by looking at the scattering of their molecules. In Aim 1, we
will optimize the SWIRRI system for imaging above 1500 nm and quantify the depth and resolution of SWIRRI.
We then apply this method in two areas: first, to study wound healing and infections, helping us distinguish
between normal inflammation and bacterial infection; and second, to examine cancerous tumors, focusing on
how they change surrounding tissues and help identify cancer spread to nearby lymph nodes.
In our second aim, we create new fluorescent dyes that work effectively in the longer wavelengths of the SWIR
spectrum above 1500 nm. While existing dyes like indocyanine green (ICG) are useful in SWIR imaging, they
are inadequate for visualizing deep structures. We plan to develop new probes that are more efficient, produce
higher contrast images, and can be used with current SWIR imaging systems already used in clinical trials. We
will also combine our SWIRRI with these dyes to achieve higher molecular specificity and allow visualization of
arterial flow not seen on SWIRI and detection of cancer metastasis.
By combining Raman imaging and improved fluorescence imaging, this non-invasive modality can revolutionize
medical diagnostics, surgical guidance, and disease monitoring.

Public health relevance
Project Narrative Limited penetration depth hinders optical imaging in biological tissues due to light scattering and absorption. To address this challenge, we propose a novel shortwave infrared (SWIR) imaging approach that enables macroscopic Raman and fluorescence imaging above 1500 nm, where scattering is significantly reduced, allowing for clear visualization of subcutaneous structures. Our research aims to enhance imaging depth and contrast by leveraging label-free SWIR Raman imaging and developing fluorophores optimized for 785 nm excitation with fluorescence signals well beyond 1500nm, facilitating deep-tissue imaging with improved resolution and clinical applicability.